Development of tools and knowledge to facilitate the investigation of chloride channel regulator CLCA2 in rare human diseasses

ABSTRACT:
The calcium-activated chloride channel regulator CLCA2 has been associated with and suggested as a
drug target for inflammatory diseases of the airway and gastrointestinal tract including the rare disease cystic
fibrosis (CF). However, a detailed understanding of its biological functions has lagged far behind its association
with these diseases, largely due to complete lack of biochemical knowledge and quality antibody reagents. We
recently made groundbreaking advances investigating fellow family members, CLCA1 and CLCA4, by showing
that they are self-cleaving metalloproteases that potentiate the calcium activated chloride channels TMEM16A
and TMEM16B, respectively. In our preliminary data we show that CLCA2 can also potentiate a calcium-
activated chloride channel in human cells. Therefore, we are uniquely poised to generate significant advances
in our understanding of CLCA2 function in health and disease. This pilot project will develop the knowledge
base and tools required to facilitate this. In Aim 1, we will investigate the mechanism of regulation of CLCA2
activity and comprehensively identify the TMEM16 family member modulated by CLCA2. In Aim 2, we will
develop a novel panel of monoclonal antibody reagents specific for the mature, cleaved forms of CLCA2 (N-
CLCA2 and C-CLCA2) that can be used in several experimental formats, and carry out initial analysis of
healthy and diseased CF airway tissues and cell samples with them. The long-term goal of this project (beyond
this pilot R03) is to develop a comprehensive mechanistic understanding of CLCA2 function in health and
disease, which could provide new therapeutic routes to treat CF and other muco-obstructive diseases, as we
demonstrate in our preliminary data. Successful completion of this pilot will provide the knowledge and tools to
investigate the functional roles of CLCA2 in CF, with the potential to develop targeted therapeutics in
subsequent projects, as well as provide insight into CLCA2 links in asthma, COPD, infectious diarrhea, Crohn’s
disease, ulcerative colitis, and some cancers.

Public health relevance
PROJECT NARRATIVE (RELEVANCE): The calcium-activated chloride channel regulator 2 (CLCA2) has been associated with and suggested as a drug target for a variety of inflammatory diseases and cancers in mucosal surfaces of the airway and gastrointestinal tract including rare diseases such as cystic fibrosis, as well as COPD, asthma, infectious diarrhea, Crohn’s disease, ulcerative colitis, and cervical cancer. However, a detailed understanding of its biological function, required to target it in disease, has lagged far behind its association with these diseases, largely due to a lack of basic biochemical knowledge and useful antibody reagents specific to CLCA2. This pilot project will develop the tools and knowledge needed to understand the underappreciated role of CLCA2 in health and disease and with the potential to leverage this knowledge to design therapeutic routes for cystic fibrosis.